The role of heparan sulfate modification on neurexin1 in synapse development

Proper synaptic function relies on a dedicated assembly of pre- and postsynaptic proteins. Neurexin1 is a
principal presynaptic organizing protein essential for synaptic function. Mammalian neurexin1 has three
isoforms (α, β, and γ). While neurexin1α and β have laminin/neurexin/sex hormone (LNS) domains, 1γ lacks
LNS domains. This is important because LNS domains of neurexin1 bind to post-synaptic partners such as
neuroligins, which recruit proteins for proper synaptic function. Deleting neurexin1α globally or neurexin1 α and
β in hippocampal neurons impairs postsynaptic receptor activation without affecting presynaptic function at
CA3-CA1 synapses. Thus, whether and how neurexin1 organizes presynaptic terminals is unclear. Recently,
we made the surprising discovery that all three neurexin1 isoforms are covalently attached to a complex
glycan, heparan sulfate (HS). We generated a Nrxn1ΔHS mouse line to block HS attachment to all three
neurexin1 isoforms and found severe deficits in presynaptic function and synapse ultrastructure. In this
proposal, we have generated a Nrxn1-/- mouse line to delete all three isoforms and found similar presynaptic
deficits at CA3-CA1 synapses in Nrxn1ΔHS and Nrxn1-/-. These findings now suggest that the neurexin1 protein
backbone alone is insufficient for presynaptic function and that additional factors, which act through HS, are
involved in presynaptic development. Furthermore, the presynaptic deficit observed in Nrxn1-/- was not found in
neurexin1 α and β mutants, raising the exciting possibility that neurexin1γ is sufficient to maintain presynaptic
function. Thus, our central hypothesis is that the HS modification has a specific role in neurexin1-mediated
presynaptic assembly and function and is essential for the roles of neurexin1γ and a novel HS-binding growth
factor pleiotrophin in presynaptic assembly and function. To test this hypothesis, we will examine the specific
role of HS in neurexin1-mediated pre- and post-synaptic assembly (Aim 1), the sufficiency of neurexin1γ and
its HS in presynaptic assembly and function (Aim 2), and the role of pleiotrophin in presynaptic assembly and
function (Aim 3) in mouse brains. To understand the synaptic assembly within an intact brain circuit, we will
utilize innovative Expansion Microscopy to visualize synaptic proteins in the higher order at individual
synapses. Given the critical role of neurexin1 in synapse development, the expected outcome of this work will
provide novel molecular insights into presynaptic development and function. Mutations in neurexin1 and
abnormalities in the biosynthesis of HS have been linked to schizophrenia and autism. Therefore, our work will
shed light on how mutations in neurexin and heparan sulfate biosynthetic enzymes affect synapse
development and function in autism and schizophrenia and may lead to the development of novel therapeutic
strategies for these diseases.

Public health relevance
The proposed research is highly relevant to public health, as it investigates the connection between a neurexin1-mediated core synaptic pathway and the heparan sulfate-mediated pathway, which have both been implicated in autism, schizophrenia, and intellectual disability. Our proposed studies aim to link two pathways and shed light on the biological significance of the heparan sulfate attachment to neurexin1 in vivo, as well as uncover the underlying molecular mechanism. By doing so, we hope to unravel a unified mechanistic understanding of the synaptic abnormalities in these diseases.